Non-invasive hemodynamic and biomechanic imaging methods for early risk prediction in aortic dissection

PROJECT SUMMARY/ABSTRACT
Aortic dissection (AD) is a disease characterized by sudden tearing of the inner layers of the aortic wall creating
a false lumen (FL) channeling aortic blood flow. The vast majority of acute AD patients survive into the chronic
phase, although long-term outcomes are poor with about 50% of patients experiencing aorta-related mortality or
requiring surgical repair by 10 years. A major contributor to poor long-term outcomes is growth of the FL. Thoracic
endovascular aortic repair (TEVAR) is a minimally invasive surgical therapy which can halt FL growth and reduce
AD mortality; however, this treatment comes with cost, risk of procedural complications, and is less effective over
time owing to increased tissue stiffness. Accurate prediction of disease trajectory at early phases is limited with
current metrics but is highly desirable as this would allow TEVAR to be targeted to high-risk patients in a timely
manner, sparing those at lower risk from potentially unnecessary procedures. Current methods for estimating
risk in AD are largely based on anatomic metrics (e.g., aortic diameter), which poorly capture functional aspects
of AD. To overcome these limitations, we propose to apply advanced imaging techniques, namely 4D Flow
magnetic resonance imaging (MRI) and 4D computed tomography angiography (CTA), to characterize and
quantify functional processes such as FL pressure and FL wall stiffness, which elude current imaging approches
and have been implicated as important factors in predicting long-term behavior of AD. We hypothesize that
assessments of these functional metrics will, improve our prediction of false lumen growth rate (FLGR) compared
to standard anatomic metrics. We plan to prospectively recruit patients with either uncomplicated type B (n=30)
or surgically repaired type A (n=45) aortic dissection to undergo baseline 4D Flow and 4D CTA imaging in the
subacute period (1-3 months post-dissection) as well as follow-up studies at 1- and 2-years post-dissection, with
the primary outcome being FLGR. To achieve these goals, the Aims of this proposal are: 1) Identify baseline
hemodynamic and biomechanical metrics in the subacute period of AD that predict FL growth rate over time. FL
pressure will be quantified from 4D Flow MRI using indirect and direct methods based on physics-based image
analysis, with regional FL wall stiffness quantified by merging FL pressure with cyclic aortic wall deformation by
4D CT; 2) Determine the trajectories of functional metrics over time that best predict progressive FL growth.
Longitudinal changes in pressure and wall stiffness between baseline and 1- and 2-year follow-up scans will be
assessed to identify patients who achieve a new equilibrium versus those who continue to progress; 3) Develop
a clinical assessment tool to predict risk of progressive FL growth combining functional metrics, anatomic
parameters and patient characteristics with a focus on simplicity and accuracy for dissection-type specific
prediction of the FLGR at the earliest possible time point. This work seeks to shift the paradigm of AD assessment
from pure anatomic characterization by integrating functional imaging biomarkers to provide accurate predictions
of disease trajectory and allow for optimal determination of surgical candidacy and timing.

Public health relevance
PROJECT NARRATIVE Aortic dissection (AD) is a potentially lethal disease, with chronic patients subjected to lifelong risks (such as aortic growth, rupture and death) that require specialized care, lifelong follow up and potentially repeat interventions. Current techniques for predicting risk in AD patients are limited and largely based on simple anatomic measurements which do not capture the functional processes believed to play an important role development of aortic growth and complications. Using a combination of state-of-the-art medical imaging techniques, this project will deliver functional measures of aortic pressure and wall stiffness, enabling us to shift the paradigm of patient assessment to provide timely, individualized medical and surgical care.